MyPEEPS Mobile Plus: A Multi-Level HIV Prevention Intervention for Young MSM

PROJECT SUMMARY
Men who have sex with men (MSM), especially young Black and Latino MSM, have the highest rates of HIV
diagnoses in the United States (US), illustrating the need for efficacious HIV prevention tools for these
populations. In response to the burgeoning HIV epidemic in young MSM (YMSM), our study team adapted the
theory-driven, group-level, evidence-based MyPEEPS intervention for diverse YMSM (R34MH079707; PI:
Garofalo) into an mHealth intervention, MyPEEPS Mobile, to overcome challenges of an in-person group
intervention. MyPEEPS Mobile is a sexual health intervention delivered through peer avatars whose personal
backgrounds and sexual risk scenarios are composites derived from formative research among YMSM, which
identified personal, family-based, and relational challenges influencing sexual health. The MyPEEPS Mobile
Trial data have shown evidence of efficacy, feasibility, acceptability, and high satisfaction by participants 13-18
years of age. Despite very promising results, pre-exposure prophylaxis (PrEP) initiation to date over the course
of the study has been extremely low in our sample (3%), which we partially attribute to a dearth of information
on PrEP content in MyPEEPS Mobile and the very young age (13-18 years) of our study participants, for whom
PrEP was not approved at the time of data collection. In response, our study team proposes to expand
MyPEEPS Mobile to develop MyPEEPS Mobile Plus, a multi-level intervention comprised of MyPEEPS
Mobile with added PrEP content (based upon expert advisory and youth feedback) + PrEP E-Peer Navigation
to overcome the challenges of PrEP initiation, adherence, and persistence among YMSM. Peer navigation is
an evidence-based, widely recommended intervention for reaching youth and MSM for HIV-related care
outcomes, with evidence of acceptability among racial/ethnic minority YMSM for PrEP. Peer navigation
addresses common reasons for failing to begin or maintain PrEP use, including low perceived risk, structural or
logistic barriers to care engagement, and anticipated side effects. Relative to in-person and group-based HIV
prevention programs, behavioral interventions with digital and virtual components can have vast reach and
present unique potential to rapidly scale delivery to very large and hidden groups. Therefore, we propose to
conduct a randomized controlled trial to test the efficacy of MyPEEPS Mobile Plus (a multi-level intervention
comprised of MyPEEPS Mobile + PrEP E-Peer Navigation) for promoting initiation, adherence, and
persistence of PrEP and decreased HIV risk behavior in YMSM. Building upon our team’s demonstrated ability
to enroll large numbers of young racially and ethnically diverse YMSM and extensive experience developing
mobile health interventions, the proposed study will test the efficacy of this expanded, multi-level mobile HIV
prevention intervention emphasizing PrEP. If efficacious, it will increase PrEP initiation, adherence, and
persistence and decrease overall HIV risk in diverse YMSM in the US.

Public health relevance
PROJECT NARRATIVE HIV incidence, although having declined modestly overall in the United States, remains a significant public health problem for young men who have sex with men (YMSM), among whom HIV rates have risen with notable racial, ethnic, and geographic disparities. In response to the continuing HIV epidemic in YMSM and disparities in initiation of and adherence to pre-exposure prophylaxis (PrEP), our study team proposes to expand MyPEEPS Mobile to develop MyPEEPS Mobile Plus, a combination intervention comprised of MyPEEPS Mobile + PrEP E-Peer Navigation to overcome the current challenges of PrEP care among YMSM. If efficacious, MyPEEPS Mobile Plus will support PrEP initiation, adherence, and persistence and decrease HIV risk in diverse YMSM in the United States.